Nucleus accumbens inputs and cell types mediating the incubation of oxycodone craving

Project Summary
Individuals with Opioid Use Disorder continue to remain vulnerable to relapse due to craving for the drug during
abstinence. I will study oxycodone (Oxy) craving using the incubation of craving model, in which rats show
progressive intensification of cue-induced seeking for drugs of abuse including Oxy during the weeks after ending
drug self-administration. Craving then remains high for an additional period before declining. Our published
behavioral data show that incubated Oxy seeking requires upregulation of Ca2+-permeable AMPA receptors (CP-
AMPAR) on medium spiny neurons (MSN) in both Core and Shell subregions of the nucleus accumbens (NAc).
Our preliminary data show this occurs on both of the main MSN subtypes: DA D1R-expressing MSN (D1+) and
adenosine A2a/DA D2R-expressing MSN (A2a/D2+ MSN; A2a and D2 receptors co-localize). I propose to extend
our knowledge of pathways (Aim 1) and MSN subtypes (Aim 2) involved in Oxy incubation. One candidate input
originates in the basolateral amygdala (BLA). Our preliminary electrophysiological data show elevated CP-
AMPAR levels in both BLA-Core and BLA-Shell pathways after Oxy incubation. Besides our data, there have
been no studies of these pathways in Oxy incubation. Therefore, in Aim 1, I will use whole cell patch clamp
recordings to measure the contribution of CP-AMPARs to synaptic transmission in the BLA-Core and BLA-Shell
pathways onto D1+ or A2a+ MSN. I will use D1-Cre and A2a-Cre rats crossed with TdTomato reporter rats (D1-
Td, A2a-Td) to selectively patch D1+ or A2a+ MSN. I hypothesize that CP-AMPAR upregulation will occur on
both MSN subtypes. I will then determine if inhibition of these pathways disrupts incubated cue-induced Oxy
seeking. The inhibitory DREADD AAV-hM4Di will be infused into BLA, and CNO will be delivered into Core or
Shell to inhibit nerve terminals prior to a seeking test. I hypothesize that both BLA-Core and BLA-Shell pathways
contribute to Oxy incubation. For Aim 2, it is known that the mu-opioid receptor (MOR) is expressed on a subset
of D1+ MSN and A2a+ MSN in NAc. However, the potential role of these MOR+ MSN in incubated Oxy seeking
has not been investigated. First, I will determine excitatory synaptic properties of MOR+ MSN compared to MOR-
MSN after Oxy incubation. Cre-dependent AAV expressing eYFP under control of the MOR promoter will be
infused in Core or Shell of D1-Td or A2a-Td rats, enabling differentiation of MOR+/D1+, MOR-/D1+, MOR+/A2a+
and MOR-/A2a+ MSN. For each, I will determine synaptic properties (paired pulse ratio, AMPA/NMDA, and CP-
AMPAR levels). Second, I will determine if MOR+ MSN are necessary for incubated Oxy seeking by infusing
AAV-DIO-hM4Di into Core or Shell of MOR-Cre rats. I hypothesize that MOR+ MSN will exhibit distinct plasticity
and contribute to Oxy incubation. This project will address a literature gap for understanding incubation of Oxy
craving while providing rigorous training in electrophysiology, chemogenetics and experimental design. This
proposal will also advance my professional development through writing manuscripts and attending professional
conferences, enabling me to become a well-rounded scientist competitive for future PI or staff-scientist positions.

Public health relevance
Project Narrative This project uses a rat model for cue-induced oxycodone craving after prolonged abstinence, a contributor to relapse vulnerability in humans, to study synaptic plasticity in the nucleus accumbens mediating this craving. The basolateral amygdala input to the nucleus accumbens is important in processing of drug cues and the mu- opioid receptor, expressed in the nucleus accumbens, is the major target of oxycodone. Therefore, I will investigate the role of basolateral amygdala projections to the nucleus accumbens and mu-opioid receptor expressing neurons in the nucleus accumbens in cue-induced craving for oxycodone after prolonged abstinence.